Metabolic regulation of the anti-tumor CD8+ T cell response to PD-1 by asparagine

Abstract
The T cell co-inhibitory checkpoint programmed cell death 1 (PD-1) plays a critical role in the maintenance of
peripheral immunological tolerance. However the PD-1 pathway can be co-opted by chronic pathogens and
tumor cells to promote immune evasion. Immune checkpoint blockade (ICB) using antibodies that block the PD-
1/PD-L1 ligand interactions have demonstrated remarkable success in cancer clinical trials. Despite inducing
durable responses in a subset of patients, most patients do not develop stable remission after therapy. Therefore,
it is critical to understand the immunological and cellular features associated with response and resistance to
ICB. Metabolic remodeling is intrinsically linked to the development, differentiation and activation of immune
cells, including anti-tumor T cells. Yet, little is known about the metabolic vulnerabilities of anti-tumor T cells,
including metabolic pathways that govern the reinvigoration of exhausted anti-tumor T cells during ICB therapy.
Our preliminary studies identified asparagine synthetase (Asns) as a novel metabolic regulator of the anti-
tumor CD8+ T cell response to anti-PD-1 therapy and provided evidence for a central role for asparagine
metabolism in regulating the efficacy of anti-PD-1 treatment in CD8+ T cell-mediated control of tumors. We will
test this hypothesis in two aims: 1) Define the metabolic pathway(s) regulated by asparagine metabolism in anti-
tumor CD8+ T cells and 2) Determine the role of asparagine metabolism in regulating CD8+ T cell exhaustion in-
vivo during PD-1 blockade. In Aim 1 we will systematically determine the metabolic mechanism(s) by which
asparagine regulates CD8+ T cells by comparing wild-type and CRISPR/Cas9-edited Asns-/- anti-tumor CD8+ T
cells. The fate(s) and contribution(s) of asparagine to distinct metabolic pathways, protein synthesis, and cytolytic
T cell activity will be assessed using isotopically labeled forms of asparagine, aspartate and glutamine in a novel
co-culture system with T cells and tumor cells. Aim 2 will comprehensively interrogate the roles of asparagine
metabolism, including asparagine synthesis and uptake, by leveraging functional genomic perturbation
approaches to target asparagine synthetase and the asparagine transporter SLC15A in exhausted CD8+ T cells
during anti-PD-1 treatment in tumor bearing-mice. Combinatorial approaches in which asparagine is
supplemented or pharmacologically depleted will reveal how modulation of this pathway regulates anti-tumor T
cell function and synergizes with ICB.
Our research is conceptually novel and will address an important gap in our understanding of metabolic
circuits critical for the maintenance and functional responses of exhausted anti-tumor CD8+ T cells during anti-
PD-1 therapy. Since little is known about metabolic pathway usage and vulnerabilities of T cells within a nutrient
limited tumor microenvironment, the identification and successful validation of asparagine metabolism as a
central metabolic node that regulates anti-PD-1 efficacy may ultimately enable novel clinical strategies to improve
the clinical response to ICB therapy by providing metabolic support to T cells.

Public health relevance
Project Narrative Despite the clinical success of PD-1 blockade in treating multiple cancer types by alleviating suppression of anti- tumor T cell responses, the majority of cancer patients do not achieve durable remission. The proposed research will investigate metabolic pathways involved in the regulation of anti-tumor T cell function and responsiveness to PD-1 blockade. The goals of our studies are to identify the metabolic requirements of effective anti-tumor immunity and to define novel metabolic intervention strategies that may synergize with PD-1 blockade.